Ribosomal RNA Methylation Regulation of Longevity and Stress Resistance

Project Summary
The goal of this project is to understand how ribosomal RNA methylation can regulate translation of specific
proteins to regulate aging. Disruption of the proteome is a hallmark of aging. Having the capacity to express
the appropriate protein in response to environmental cues is an essential and evolutionarily conserved
process. Therefore, preserving the proteome is critical for maintaining organismal health and healthy aging.
However, how aging-responsive mRNAs are selectively translated is unknown. We recently identified that
ribosomal RNA methylation could facilitate the translation of a specific subset of proteins. Additionally, we
characterized how ribosome occupancy changes as an organism ages and determined that changes in
ribosomal DNA methylation are sufficient to project the organismal age. Whether ribosomal RNA methylation
plays a role in preserving proteome integrity as organisms age is still unclear. We have recently found that
enzymes which regulate RNA methylation and RNA methylation itself are dysregulated during aging and in
response to stress. We found that an N6-adenosine methyltransferase, METL-5, directly methylates adenosine
1717 on 18S ribosomal RNA in C. elegans. Methylation of adenosine 1717 enhances ribosomal binding and
selective translation of specific mRNAs. Our preliminary data shows that metl-5 deficient animals grow
normally under homeostatic conditions; however, metl-5 mutants are resistant to a variety of stresses,
including heat shock and UV irradiation. We also have preliminary data that deletion of an N6-dimethyl
adenosine (m6,2A) methyltransferase, DIMT-1, which methylates adenosines 1735 and 1736 on 18S rRNA
regulates selective ribosomal binding and translation of specific mRNAs and causes increased longevity and
stress resistance. Thus, methylation of specific residues of the 18S rRNA by METL-5 or DIMT-1 selectively
enhances translation of specific transcripts to regulate stress resistance and longevity. However, whether
rRNA methylation more broadly can regulate age and stress-responsive translation and how this dysregulation
drives the aging process is still unknown. Our preliminary findings suggest that ribosomal RNA methylation can
facilitate selective translation of specific transcripts providing another layer of regulation of the stress response
and aging. Capitalizing on this preliminary data we will use genetic, biochemical, and molecular approaches
both in vitro and in vivo to dissect the role of rRNA methylation in regulating aging and stress resistance. Our
underlying hypothesis is that rRNA methylation promotes ribosome heterogeneity in response to stress
conditions and aging to facilitate the appropriate translation of stress resistance transcripts.

Public health relevance
Narrative Historically ribosomes were believed to translate whatever transcript they were presented with, but recent studies suggest that ribosome composition varies and plays a significant role in the regulation of translation. This proposal will provide insight into how methylation of ribosomal RNA changes with age to produce specialized ribosomes to control the translation of specific transcripts in response to environmental stressors and organismal aging. We have found that methylation of 18S ribosomal RNA plays a crucial role in regulating longevity and the stress response in C. elegans and propose to identify the molecular basis by which methylation of rRNAs specify distinct translational outcomes in response to environmental stimuli.